Preclinical Efficacy and Safety Evaluation of Oral AST-004 for Moderate Traumatic Brain Injury (TBI)

PROJECT SUMMARY
Traumatic brain injuries (TBI), including concussions, are an area of significant unmet need with no approved
therapeutics and a national burden of ~$77 billion annually. TBI is the global leading cause of post-injury death
and disability, and over 2 million Americans sustain a TBI each year. Approximately 1 out of every 60 people in
the U.S. lives with a TBI-related disability. The tremendous incidence and long-term consequences of TBI
highlight the considerable epidemic at hand, and the need for neuroprotective treatments.
Astrocyte Pharmaceuticals Inc. is developing the proprietary small molecule pharmaceutical agent AST-004 for
acute administration to TBI patients that will dramatically improve the survival of neurons, affected brain tissue,
and the long-term neurological deficits that have been linked to TBI. The proprietary approach at Astrocyte
Pharmaceuticals differs significantly from historical neuroprotective attempts in that it focuses on a non-
neuronal cell type, the astrocyte, which has only recently received broader attention as an important cellular
target for successful therapeutic research. AST-004 enhances and maintains astrocyte mitochondrial function
and improves multiple healing mechanisms including protection against edema, glutamate excitotoxicity, and
oxidative stress.
Previous NINDS Phase I STTR-funded research contributed to the identification of AST-004 and the
demonstration of its efficacy when intravenously (IV) administered in a large animal pig TBI model. This
promising IV therapy has advanced through Phase 1 human clinical trials as an in-hospital IV formulation. For
the mild to moderate TBI population, an extended IV infusion is not a pragmatic or commercial option. To
address this large patient population and enable further clinical trials, we are developing an oral tablet
formulation for use outside the hospital setting. The goal of this Direct-to-Phase II project is to complete critical
path preclinical activities to advance the oral formulation to the clinic. Specifically, the project aims to (1) verify
efficacy using the oral route of administration in a large animal model of TBI, and (2) perform the FDA-required
preclinical toxicology studies. Successful completion of this project will lead to an IND submission of the AST-
004 oral tablet formulation with the FDA and a subsequent Phase I clinical trial.

Public health relevance
PROJECT NARRATIVE Traumatic brain injuries (TBI), including concussions, affect over 2 million Americans each year, and TBIs are a leading cause of death and disability. Currently, there are no FDA-approved pharmaceutical treatments for TBI. Astrocyte Pharmaceuticals Inc. aims to develop the first TBI therapeutic to limit neuronal damage and the physical, cognitive, and emotional complications associated with mild to moderate TBI.